Specimen and Data Core

Summary - Specimen and Data Core
The proposed Specimen & Data Core will serve several central roles within this highly
integrated Program Project: 1) it will consent and enroll all Merkel cell carcinoma (MCC) patients into
our longitudinal research study; 2) it will acquire, process, and store all patient biospecimens (blood,
fresh and archival tumor tissue, stool) and distribute them to the relevant Projects and the
Immunopathology Core; and 3) it will obtain patient clinical data over time, and store research-derived
patient results, annotating the samples with corresponding disease status. The proposed Core will
expand both our existing MCC Specimen Repository that has over 40,000 individual specimens from
more than 1,850 patients (as of May 2024) and our Relational Database that annotates those samples
and patient demographics using approximately 300 data fields including clinical treatments, disease
status, and response data, as well as research laboratory results.
An essential role for the Specimen and Data Core will be to acquire tumor samples from
patients before and after PD-1 checkpoint blockade therapy. Obtaining such tissues is complex and
laborious but also essential for understanding the basis of response and non-response to these
important new immune therapies. A recent expansion of our relational database involves the addition of
over 30 fields to capture new immunotherapy-related results and experimental data that will be useful
for the Projects as well as for the Immunopathology Core and the Bioinformatics and Biostatistics Core.
The Specimen and Data Core will also track MCPyV oncoprotein antibody titers to assist in a) detecting
early disease recurrence, b) understanding how to use this test in patients undergoing PD-1 checkpoint
blockade therapy, and c) supporting Project 3 in understanding the biological basis of why these
antibodies are associated with better outcomes, despite the fact that an antibody to an intracellular
protein cannot directly contribute to tumor cell killing. This Core will also assess how best to use the
new ctDNA test for measuring tumor burden and for predicting recurrences in MCC patients.
Finally, the Specimen & Data Core will leverage these precious resources by sharing samples
and data with the broader MCC and scientific communities through collaborative studies that have
proven extremely productive, with 46 publications since our initial P01 grant submission in 2018 that
have made use of repository specimens and data. Six of those publications were led by investigators
outside of Seattle and not integral to this P01.

Public health relevance
Narrative - Specimen and Data Core The Specimen & Data Core will oversee patient enrollment and the acquisition & processing of patient samples and clinical data. It will distribute samples and clinical outcomes data to the three Projects, the Immunopathology Core, the Bioinformatics and Biostatistics Core, and through strategic collaborations, to the broader scientific community. The Core will also track MCPyV oncoprotein antibody titers and circulating tumor DNA longitudinally in order to assist in the early detection of disease recurrence, to characterize these clinical tests in the setting of PD-1 checkpoint blockade, and to study the mechanistic basis of these test by providing samples to Project 3.